EFFECT OF MICRONIZED PROGESTERONE ON MARKERS OF BONE TURNOVER

This study was designed to examine the effect of micronized progesterone on postmenopausal women who are on estrogen therapy, which might enhance the effectiveness of estrogen.